The Biochemical Basis for the Mechanics of Cytokinesis

PROJECT SUMMARY
GM66817-18 PARENT GRANT
Cell shape change is fundamental for cell division, migration, and tissue formation, and defects in cell shape
change are one of the early hallmarks of disease. In our research, we study cell shape change, focusing on the
biomechanical systems, and we utilize cytokinesis as an elegant model process. Over the life of this grant, we
have demonstrated how an interplay of active force production, cortical tension, surface curvature, and
viscoelasticity drive cell shape change, including cytokinesis furrow ingression. We identified key molecular
pathways that control these properties and found that the circuitry is wired like a control system complete with
feedback loops that allows mechanical and chemical signals to tune the accumulation of the contractile
machinery. In this proposal, we will build upon our understanding of cell shape change and the mechano-
responsive contractility network. We use a suite of techniques, including genetics, proteomics, Single Molecule
Pulldown (SiMPull), and Fluorescence Correlation and Cross-Correlation Spectroscopy (FCS/FCCS) to study
this network. We discovered that many of the proteins in the mechano-responsive contractility network are
organized into complexes in the cytoplasm, forming Contractility Kits (CKs). Several CK components have
unknown functions in the context of cell contractility and are the subject of this proposal. Among these, the lectin
discoidin 1A, traditionally viewed as a secreted protein, assembles with the CKs in the cytoplasm and is
necessary for a key protein, the actin crosslinker cortexillin I, to localize fully to the cortex. Moreover, discoidin
1A has a complex genetic relationship with cortexillin I and its binding partners, IQGAP1 and IQGAP2. We will
determine how discoidin 1 operates in the CKs and promotes cortical assembly. Next, we are studying two
ribonucleoproteins, RNP1A and RNP1B. Both proteins contain predicted RNA-recognition motifs. RNP1A is also
required for normal cortexillin I mRNA levels. We originally identified RNP1A over-expression as a genetic
suppressor of the microtubule-destabilizer nocodazole (same study that gave rise to the RacE-14-3-3-myosin II
pathway that we discovered). We have now found that RNP1A is required for normal microtubule length, cell
adhesion, and cortical mechanics. We conducted RNAseq analysis and found that several CK proteins have
altered gene expression in rnp1A knockdown cells. To identify RNAs that the RNP1s might bind, we have used
CLIP-Seq and identified several RNAs as interactors of RNP1A and RNP1B. One of particular interest is the
dynamin-like protein 1, which localizes to the cleavage furrow cortex where it assists in actin and myosin II
organization. Others are involved in macropinocytosis, another essential cell shape change event that also draws
upon much of the CK machinery. Here, we will flesh out how the RNP1s impact CK assembly, expression, and
function. Overall, these studies will decipher how the CK network operates and integrates with other cellular
systems, leading to a deeper understanding of cell shape change processes more generally.

Public health relevance
PROJECT NARRATIVE GM66817-18 PARENT GRANT Cell shape control is essential for the proliferation of cells, normal development, and maintenance of a healthy organism. We study the biochemical basis of the mechanics of cell shape control, striving for a rigorous molecular handle on how these processes occur with high fidelity and how they are altered during disease.